Methamphetamine, HIV integration and latency in the brain

Methamphetamine, HIV integration and latency in the brain
Methamphetamine (Meth), a stimulant drug used by people with HIV (PWH
pathways in addiction, aggravating effects of HIV in the brain, where reservoir cells bearing HIV integrated
provirus challenge cure strategies and contribute to perpetuating neurological consequences, despite
), influences inflammation and
antiretroviral treatments (ART).
Neurotransmitters involved in addiction such as dopamine (DA) modulate HIV
targets that express DA receptors, including the microglia diverse population. Chromatin organization in HIV-1
integration represents an important prerequisite for understanding infection and latency. However, there is a
critical gap in understanding relationships between chromatin organization and proviral integration associated
with HIV-1 persistence in microglia cellular reservoirs, and particularly in the best experimental model, the SIV-
rhesus macaque. Moreover, it is unknown how Meth modifies these relationships. We hypothesize that Meth
impacts chromatin enhancing viral integration susceptibilities in HIV/SIV brain target cells, and that effects vary
by brain region that differ in dopaminergic projections.
Critical to this goal is the progression of models reflected
in phases, first in vitro using human microglia cell lines and iPSC-derived, where the characteristics of HIV
integration have been defined, and effects of Meth, or DA, can be controlled. This is followed by models ex vivo
and in vivo in the SIV-rhesus macaques, to replicate HIV, chronic Meth and ART-suppression. In the R61 phase,
we will concentrate on whether chromatin accessibility and the architectural protein CTCF, which interacts with
LEDGF/p75 to tether the HIV-1 Integrase, mediate insertions into genomic boundaries of topologically associated
domains (TADs), modified by Meth, or DA. We will assess the impact of integration patterns on the integrity of
proviral genomes to gain insights about the real size of the functional viral reservoir. Aim 1) delineates
relationships between epigenomic changes in microglia upon Meth and proviral genomes inserted into the pre-
established regions with marked presence of CTCF and H3K36me3 (TAD boundaries), Aim 2) connects
epigenetic profiles and HIV-1 insertion patterns with the cellular and viral transcription profiles, while confirming
these rules in the SIV system, and Aim 3) determines the contribution of DA. Go-No-Go: If epigenomic changes
caused by Meth or DA are linked to integration sites, with similar rules in all models, the R33 phase will move to
the in vivo SIV model, to test effects of Meth chronic use on epigenomic vulnerabilities to SIV integration in
microglia, in relation to subset heterogeneity in mesolimbic areas where DA projections are abundant compared
to control regions of the brain. Aim 4) tests whether SIV integration site availability follows rules dictated by
chromatin states, accessibility and CTCF binding that can be used to predict susceptibilities in the context of
Meth. Aim 5) tests whether integration susceptibilities and patterns vary in brain areas that differ in dopaminergic
projections, and heterogeneous microglia populations. This project enables novel studies on microglia chromatin
and SIV integration dynamics in brain areas that differ by function, cellular density, and neurotransmitters.

Public health relevance
Methamphetamine, HIV integration and latency in the brain This project addresses a critical gap in our understanding of relationships between chromatin organization and proviral integration associated with latency in brain microglia cellular reservoirs of HIV, and particularly in the best experimental model, the SIV-rhesus macaque. While HIV integration and latency in tissues such as the brain are challenges to the cure, the relationships between HIV integration and chromatin dynamics may be drastically different in prevalent populations of HIV+ drug users, especially Methamphetamine. Following a two phase project, where a progression of models will lead to conclusions about HIV/SIV integration site frequency, location and markers, we expect to prove our hypothesis that Meth impacts chromatin structure in microglia, enhancing viral integration susceptibilities and that these effects vary between brain regions that differ in levels of dopaminergic projections, and their involvement in the addiction circuitry, leading to a paradigm shift about the role of brain regions and their heterogeneous microglia populations in the establishment of a reservoir state.